Developing deep learning algorithms for studying infant brain and behavior relationships

Project Summary Infants communicate to their caregivers that they need food by crying. This represents our very first social interaction that lays the foundation for a healthy life by acquiring nutrition for growth and establishing a strong social bond with caregivers. Infants that cannot regulate their nutrition are at risk for malnourishment or obesity, whose deleterious effects will negatively impact the wellness of these individuals for their lifetime. Abnormalities in social recognition and communication, like those found in autism spectrum disorders, also become apparent during infancy. Despite the critical importance of infants communicating nutritional need to caregivers, the neuronal basis remains unknown. To address this deficit, I propose to study social tadpoles that beg their parents for food by dancing. Tadpoles use this begging display to encode nutritional state, enabling us to quantify hunger- based communication. These tadpoles are translucent, allowing us to visualize the development and activity of neurons in the brain. I am combining this novel model system and behavioral paradigm with advanced neurogenetic tools to interrogate the neuronal substrates of hunger-based communication. I will examine whether nutritional quality influences the development of neurons that regulating feeding and communication with in vivo brain imaging. I will also test for a functional role of these neuronal cell-types in begging behavior using a high throughput behavior assay, whole brain clearing and immunohistochemistry, and cell-specific manipulations of neuronal activity. As social recognition is important for establishing parent-offspring bonds, I will then use in vivo neural activity imaging to determine how tadpoles recognize their parents using multi-modal sensory integration. Completion of these experiments will transform our understanding of a social behavior critical for infant survival and life-long wellbeing. There is a pressing need for this research because there are currently no established models for studying the neural mechanisms of infant communication of hunger. This work is important to public health because some of the most prevalent disorders afflicting children in the United States are eating related disorders and conditions involving abnormalities in social recognition and communication, such as autism spectrum disorders. More research on infant feeding and communication is needed to better understand these pathologies in the youngest members of our society.

Public health relevance
Narrative Communication of nutritional need during infancy is our very first social interaction, laying the foundation for a healthy life by acquiring nutrition for growth and establishing strong social bonds with caregivers. The proposed work uses a unique biological model – social tadpoles that communicate nutritional need to their caregivers – to uncover how infants evaluate their nutritional state, recognize their caregivers, and communicate that they need food. These studies have implications for informing preventative strategies and treatments for childhood obesity and autism spectrum disorders, two of the most prevalent diseases afflicting the youngest members of our society.